Geriatric Oncology: Cognition and Communication

Geriatric Oncology Cognition and Communication
Project Summary
An important public challenge is how we address the multi-layer complexities
associated with individuals who have a cancer diagnosis and cognitive
impairment and/or functional deficits. Many organizations including the American
Society of Clinical Oncology and the Institute of Medicine have recognized the
need for more research and education about the diagnosis and management of
geriatric syndromes in patients with cancer as many healthcare providers (HCPs)
are unprepared. The proposed Geriatric Oncology Cognition and Communication
(Geri Onc CC) training program is designed to train oncologists, primary care
providers, and other HCPs (nurses, nurse practitioners, physician assistants,
social workers, physical therapists, occupational therapists) to screen for and
conduct an initial assessment to identify cognitive impairment and/or functional
decline in the older cancer patient, to learn about factors to consider when
treating older cancer patients, and to improve communication with the patient
and his/her caregiver. Two hundred fifty-two HCPs working with older oncology
patients will participate in the interactive, multi-modal two-day in person program
with ongoing professional development over a 12-month period. Training will
occur in 14 cohorts over the 5-year project. We will examine knowledge,
attitudes and uptake and use of skills before and up to 12 months after the
training. The overarching goal of this cancer educational program is to prepare
the workforce to care for this growing, vulnerable, aging population.

Public health relevance
Project Narrative This cancer education training project’s goal is to train healthcare providers (HCPs) to work more effectively with older cancer patients who may have cognitive and functional difficulties. This project is important because it will help prepare the work force to care for the growing numbers of older cancer patients and their families. Results of this study have the potential to improve the knowledge and communication skills of oncology HCPs which will benefit HCPs and older oncology patients and their families.